Sanford Community Cancer Program of the North Central Plains (NCORP)

PROJECT SUMMARY
The Sanford Community Cancer Program (SCCP) remains committed to its original goals and aims as stated in
our 2013 application. The SCCP continues to increase patient participation in cancer control, prevention, care
delivery, treatment, and imaging studies across its expanding network. The rural communities of the upper
Midwest and Central Plains represent a large underserved population for cancer treatment, care delivery and
clinical trials (PMID:24097196 PMID:22046848 PMID:19621978). The reasons for this disparity are multi-
factorial but a main obstacle is access to services in rural regional areas. Sanford Health has developed a
network of hospitals, cancer centers and clinics to provide high-quality, multi-disciplinary cancer treatment,
clinical trials, and cancer care delivery to this underserved area. Sanford Health has designated cancer care as
a Center of Excellence; elevating cancer care as a top priority to the patients it serves. The SCCP has expanded
from five to seven components in the past five years, adding two new components to improve trial access in rural
and underserved areas. It is hypothesized that this disparity in care for this rural population can be improved by
utilizing the organized SCCP network community. This proposal describes how the NCI Community Oncology
Research Program (NCORP) partnership will help deliver clinical care and offer clinical trials across the rural
area served by the SCCP. This will be accomplished through the following aims:
1. Maintain and enhance robust accrual to NCI Division of Cancer Prevention (DCP) supported
clinical trials through seven components.
2. Address disparities in clinical trial accrual in underserved and underrepresented populations to
increase participation.
3. Cultivate innovative access points to address barriers to clinical trial accrual through outreach
and telemedicine.
4. Expand Cancer Care Delivery Research infrastructure.
Through these four aims the Sanford Community Cancer Program will continue to offer NCI clinical trials and
provide state-of-the-art cancer treatment and cancer care delivery to millions of people across six states in rural
America. The SCCP's ability to provide clinical trials through outreach and telemedicine to this underserved rural
population of patients increases their opportunity for participation in a trial as a treatment option. Telemedicine
services are currently provided in existing Sanford Clinics in rural communities to deliver oncology consultations,
surveillance exams and chemotherapy oversight. As a community based health care organization, the SCCP
will participate in the development and implementation of cancer care delivery research to better understand and
improve patient outcomes. The SCCP will design and develop additional community based investigator-initiated
Cancer Care Delivery pilot projects with the goal to collaborate with the SCCP's primary Research Bases.

Public health relevance
PROJECT NARRATIVE The Sanford Community Cancer Program (SCCP) covers rural communities of the upper Midwest and Central Plains representing a large underserved population for cancer treatment, care delivery and clinical trials. The NCI Community Oncology Research Program (NCORP) partnership will help deliver clinical care and offer clinical trials across the rural area served by the SCCP. This will be accomplished through the following aims: maintain and enhance robust accrual to NCI Division of Cancer Prevention (DCP) supported clinical trials through seven components; address disparities in clinical trial accrual in underserved and underrepresented populations to increase participation; cultivate innovative access points to address barriers to clinical trial accrual through outreach and telemedicine; expand current personnel and infrastructure, and contribute to Cancer Care Delivery Research trials.